Novel Coronary Artery Vasodilator Development

PROJECT SUMMARY: Cardiovascular diseases (CVD) are the leading cause of death globally, and are
responsible for 1 in 3 deaths in the US. It is estimated that between 2015 and 2018, ~127 million US adults had
some form of CVD. Coronary heart disease (CHD) is directly responsible for ~41% of CVD deaths. Angina
pectoris, a primary symptom of CHD, is chest pain or discomfort caused by an imbalance of oxygen; the heart’s
oxygen demand exceeds its supply. This oxygen deficiency, or hypoxia, is linked to most CVD. The prevalence
of stable angina pectoris in Western countries is estimated to be over 10% in patients over 65 years of age with
an annual mortality rate of up to 3.2%, but the first symptom of CHD can be sudden death. Antianginal
vasodilators that donate nitric oxide (NO), the primary endothelium-derived relaxing factor (EDRF), are the
preferred initial treatment for symptomatic angina pectoris. Current NO-based antianginals have shortcomings
such as short-term efficacy, side effects, or tachyphylaxis; therefore, there is an urgent need for novel treatments
for angina pectoris. Coeurative, Inc. is developing novel antianginals for enhanced NO delivery. During the
funding period of this Phase I SBIR proposal, Coeurative, Inc will characterize a new class of nitric oxide (NO)
donor compounds (CR compounds) as novel antianginals. In Aim 1, the vasorelaxant activity of these
compounds will be established using coronary artery rings from human donors. During Aim 2, the production of
NO and guanosine 3’,5’-cyclic monophosphate (cGMP), a second messenger that plays a critical role in vascular
smooth muscle (and blood vessel) relaxation, by CR compounds will be compared to that of isosorbide-2-
mononitrate (IS2MN) and isosorbide dinitrate (ISDN), generic NO donors routinely administered as treatments
for angina. The completion of the proposed work will extend to Phase II studies wherein the mechanism of action
of CR compounds will be further elucidated, and their efficacy compared to that of IS2MN and ISDN in an animal
model of CHD.

Public health relevance
PROJECT NARRATIVE: There is an urgent need for new antianginals with improved long-term efficacy and fewer side effects. Coeurative, Inc is developing novel nitric oxide (NO) antianginals to facilitate the release of NO, a key regulator of cardiovascular function in systemic and pulmonary blood vessels, thereby reducing morbidity and mortality related to coronary heart disease. The development of these therapeutics will improve the quality of life for millions of individuals who suffer from chronic stable angina pectoris.